CHEMISTRY OF THE MACROCYCLIC TRICHOTHECENE ANTIBIOTICS

The macrocyclic trichothecenes area a class of potent antibiotics which possess a wide range of bioactivity including insecticidal, antifungul, antibacterial, and antiviral. They also are phytotoxic and cytoxic and exhibit a high degree of cytostacitity; the latter property makes them attractive antitumor candidates. We are to acquire large quantities of macrocyclic trichothecenes from two principal sources: 3800 lbs (dry weight) of the Brazilian shrub, Baccharis megapotamica and via fermentation of the fungus species of Myrothecium. The macrocyclic trichothecenes will be chemically or biologically modified to enhance their in vivo anticancer activity. The biosynthetic origin of the macrocyclic trichothecenes in M. verrucania has been partially established, and the route involves the trichoverrins which appear to undergo dehydrative ring-closure to give roridines E and isoE. Trichoverrins are to be synthesized with appropriate radiolabels, and the biosynthetic pathway to the various macrocyclic trichothecenes will be delineated. The bioproduction of macrocyclic trichothecenes from species of Stachybotrys and Myrothecium is to be studied with respect to increasing yields of difficult to obtain macrocyclic trichothecenes. The former organism is responsible for a number of serious cases of mycotoxicoses in Eastern Europe, and this organism has been shown to produce the macrocyclic trichothecene satratoxins, albeit, in low yield on solid media. We recently have shown that a unique strain of M. roridum (P-D/W-L-514) in liquid culture produces all the classes of the known marocyclic trichothecenes: roridins, verrucarins, satratoxins, and vertisporins. This and related strains of M. roridum as well as several toxigenic strains of Stachybotrys will be employed to produce the rare satratoxins and vertisporins to be used for anticancer drug development.